EFFECTS OF THE BOC CHALLENGE IN BODY COMPOSITION

The effect of sailing around the world alone on body composition will be determined in sailors as they leave and return to Charleston. Body composition will be determined by Dexascan. Also, dietary recalls and anthropometrics will be evaluated during the eight month sail.